Gammaherpesvirus protein kinase: a master manipulator of the host during chronic infection.

Gammaherpesviruses establish life-long infections in >95% of adults worldwide and are associated with B
cell lymphomas. Prevention of gammaherpesvirus-driven lymphomas is currently impossible due to
absence of vaccines, curative antivirals, and defined risk factors for lymphomagenesis. All
gammaherpesviruses encode a protein kinase, a key determinant of chronic infection and pathogenesis.
This grant application aims to define the molecular and cellular mechanisms underlying physiologically
relevant functions of gammaherpesvirus protein kinases during chronic infection of an intact host. Based on
our published and preliminary findings, the proposed studies test the working model that macrophage-
intrinsic IFN signaling is antagonized by an enzymatically active viral protein kinase to promote the passage
of the virus from myeloid to B cell compartment. Once viral access to B cells is gained, viral kinase
supports latent viral gene expression and engages host mechanisms to drive B cell differentiation and
establishment of chronic infection. Successful completion of the proposed studies will define molecular and
cellular mechanisms underlying functions of the conserved gammaherpesvirus protein kinase during chronic
infection of an intact natural host. Such mechanisms are likely to operate during viral lymphomagenesis
and may present novel therapeutic targets for the prevention of gammaherpesvirus-driven lymphomas.

Public health relevance
Gammaherpesviruses permanently infect most of the adult population worldwide and are associated with B cell lymphomas. The risk factors that predispose towards the development of gammaherpesvirus-driven lymphomas are not well defined and there are no vaccines or curative antivirals available for the infection. This grant application focuses on a viral protein that is shared by all gammaherpesviruses and aims to define how this viral protein supports chronic infection with the goal of generating new viral and host therapeutic targets.